Caregiver-assisted pain coping skills training for dementia

Over five million persons in the United States are living with Alzheimer's disease and related dementias
(referred to as “persons with dementia” or PWD). Most patients with early to moderate disease reside in the
community and require significant help from family caregivers. Community dwelling PWD and their family
caregivers represent a burgeoning and vulnerable population with significant unmet medical and psychosocial
needs, one of which is pain management. Pain in PWD is common and compounds the impact of dementia,
causing distress, discomfort, increased disability, and neuropsychiatric symptoms. Treatment for pain often
focuses primarily on pharmacotherapy which has significant limitations for older adults. Pain in PWD also
causes increased stress for family caregivers who are themselves at risk for adverse mental and physical
health outcomes. To date, the overwhelming majority of literature on pain management in PWD focuses on
patients with advanced disease living in long term care facilities. Given the prevalence of pain in community
dwelling PWD and the impact of pain on patients and caregivers, it is important to target pain management
efforts to both patients and caregivers together. Pain coping skills training (PCST), a non-pharmacological pain
management approach based on cognitive behavioral principles, has been found to be efficacious among older
adults without dementia. A caregiver-assisted PCST protocol adapted to meet the needs of PWD and their
caregivers represents a novel approach to pain management in this population that holds the promise of
decreasing patient pain, disability, and psychological distress, and caregiver burden. This NIH Stage 1A study
aims to refine a caregiver-assisted PCST intervention and develop study procedures in preparation for a well-
powered Stage 2 randomized clinical trial. Aims of the proposed study are: (1) To refine the caregiver-assisted
PCST intervention specifically for patients with mild-moderate dementia and determine the optimal duration
(e.g., number of sessions, session length) and mode of treatment delivery (e.g., in-person vs. remote) with
input from Community and Professional Advisory Boards and through conducting a single-arm pilot study with
30 patient-caregiver dyads. (2) To identify optimal recruitment and retention strategies with input from our
Community and Professional Advisory Boards. We will pilot and refine these strategies in the process of
piloting the intervention. Ultimately, this program of research has the potential to meaningfully advance the
clinical care of PWD and pain and enhance their quality of life and that of their family caregivers.

Public health relevance
Community dwelling patients with dementia and their family caregivers represent a burgeoning and vulnerable population with significant unmet needs, one of which is pain management. The proposed study will refine and pilot test a novel non-pharmacological caregiver-assisted pain coping skills intervention to train patients and caregivers in skills to help them manage patient pain. The intervention is expected to benefit both patients and their caregivers by improving patient pain and quality of life and caregiver self-efficacy for managing pain, caregiver burden, and caregiving satisfaction.